ADJUVANT COMPARISON AND CHARACTERIZATION

The goal of the Adjuvant Comparison and Characterization (ACC) program is to support side-by-side comparison of adjuvants in combination with clinically relevant vaccine/antigen platforms, and to establish both systemic and tissue-specific immunological profiles (“immune fingerprints”) of adjuvants that work through different mechanisms in the context of Influenza (flu), Chlamydia muridarum (Cm), and Coxiella burnetii (Cb).